Project 2: Tetravalent live attenuated dengue virus vaccines: Linkage of vaccine-induced human B cell and antibody response to protective or dengue disease-enhancing immunity

Project 2: Tetravalent Live Attenuated Dengue Virus Vaccines: Linkage of vaccine-induced human B
cell and antibody response to protective or dengue disease-enhancing immunity (UNC).
SUMMARY
The four-dengue virus (DENV) serotypes carried by mosquitoes infect several hundred million people each
year. While effective vaccines have been developed for some flaviviruses, dengue vaccines have been
challenging because antibodies to one serotype can protect or enhance viral replication and disease by
another serotype, necessitating development of tetravalent (TV) vaccines. The overall objective of Project 2
is to study clinical samples from individuals in dengue vaccine studies to reveal mechanisms of vaccine-
mediated protection, vaccine failure and vaccine-enhanced dengue disease. Central to this renewal application
is a bio-archive of >15,000 samples collected from an actively monitored cohort of children in the Philippines
who received Dengvaxia®, a TV live attenuated DENV vaccine (TV-DLAV). In Aim 1, we define the landscape
of DENV neutralizing antibodies (nAbs) and mechanisms of vaccine breakthrough infections in baseline
seronegative vaccinees. We will determine if DENV serotype-specific (TS) Abs are a better correlate of
protection than the current standard of total nAbs (Aim 1.1). We will also test if TV-DLAVs stimulate a TS nAb
response that is narrower in breadth, allowing breakthrough infections with variant genotypes, compared to WT
primary (1°) DENV infections, in collaboration with Project 1 (Aim 1.2). In clinical trials thus far, TV-DLAV
have performed better in baseline DENV-seropositive individuals compared to seronegative individuals. We
propose that the strong vaccine performance in seropositive individuals is due to the ability of even one
replicating vaccine component to activate pre-existing memory B and T cells and stimulate a strong, broad,
and durable “secondary” cross-protective response. In Aim 2, we will test this hypothesis using samples
collected from baseline DENV-seropositive children who received a single dose of Dengvaxia® (DENV4-
biased) vaccine before 5 years of active monitoring. In the original Dengvaxia® clinical trial, seronegative
subjects who received the vaccine were at a greater risk of developing dengue disease and/or being
hospitalized compared to unvaccinated controls. In Aim 3, we will analyze samples from subjects enrolled in
our Dengvaxia® cohort who subsequently experienced asymptomatic, mild or severe (hospitalized) DENV
infections to define Ab features, both at the level of antigen-specificity and Fc structure/function, correlated with
vaccine-enhanced WT infections. This Aim parallels Project 1 Aim 3. Project 2 studies are highly
interconnected with Project 1 (Ab and B cells in WT DENV infections) and Project 3 (T cell responses to
DENV infections and vaccines), sharing samples and comparing datasets. The proposed experiments and
data analysis rely on extensive interactions with Core B (Viral Assays), Core D (Antibodyomics) and Core C
(Clinical, Data Management, and Statistical Modeling). Completion of these aims will fill critical gaps in DENV
immunology and support evaluation of vaccines in the current pipeline and design of 2nd generation vaccines.

Public health relevance
NARRATIVE (PROJECT 2) Dengue is the leading mosquito-transmitted viral infection of humans, and while vaccines offer the best hope for prevention and control of dengue, the leading live attenuated vaccine candidates have performed poorly in young children, with variable levels of efficacy to each serotype. These vaccines have performed poorly because they were developed over 20 years ago, when the scientific community had a poor understanding of the properties of dengue viruses infecting humans and the human immune response to these viruses; however, as a result of studies performed over the past decade by the scientific community, including investigators in this Program Project, we now have a much better understanding of dengue virology and protective immune responses. In Project 2, we will continue to fill in gaps in foundational knowledge about protective human antibody responses in vaccinees and individuals exposed to WT dengue virus infections, with strong focus on new information and technologies needed to improve current vaccine approaches and to develop new vaccine platforms.